PREVENTIVE CARDIOLOGY ACADEMIC AWARD

The University of Maryland requests support to develop a broad- based inter-departmental curriculum and program in Preventive Cardiology. This will be targeted to medical students and a wide range of house officers and fellow in training. A concerted effort to reach both junior and senior faculty will also be made. The program will build on a unique alliance between the Division of Cardiology and the Department of Epidemiology and Preventive Medicine. Led by the above, the Departments of Family Medicine, Pediatrics, Internal Medicine and the Office of Medical Education have prominent roles, with support from basic science departments as well. Objectives include: A) Development of a Center for Preventive Cardiology to foster education, patient care and research; B) Development of an integrated, core curriculum aimed at teaching, reinforcing and verifying knowledge, attitudes, and clinical skills with respect to prevention of cardiovascular disease; C) Training in "Health Risk Assessment" for medical students, house staff, fellows and faculty; D) Development of a Faculty Educator Development Core ensuring teaching by role model throughout the program; E) Development of a weekly conference series in preventive cardiology ; F) Preparation of a regular column in the Maryland Medical Journal, "Perspectives in Preventive Cardiology," and a preventive cardiology campus newsletter; G) Development of teaching materials and evaluation instruments; H) A program for the applicant's own educational development in preventive cardiology, epidemiology and medical education. Plans for perpetuation of the program beyond the proposed funding period are also presented.